DeconDTN: Deconfounding Deep Transformer Networks for Clinical NLP

Abstract
This proposal relates to ongoing efforts to develop automated methods for the detection of linguistic
manifestations of cognitive changes in Alzheimer’s Disease (AD). These methods have the potential to alleviate
the personal and societal burden of AD, by reducing time to diagnosis. Delayed AD diagnosis has adverse effects
on care planning and family relationships, and has been estimated to cost the healthcare system close to $8
trillion dollars. Language reflects cognitive status, and contemporary neural network models have been shown
to discriminate between transcribed speech from patients with AD and that from healthy controls with promising
accuracy. However, most of this work has been conducted in the context of recorded responses to picture
description tasks, which are not suitable for repeated, continuous or passive monitoring for linguistic indicators
of AD-related decline. In contrast, our recent work has identified the task-agnostic linguistic construct of semantic
coherence as a sound basis for machine learning models for detection of language from people with AD in casual
conversations, with classification performance in this context exceeding that of Bidirectional Encoder
Representations from Transformers (BERT) based classifiers, the state-of-the-art for text-based AD detection.
Unfortunately, recent work has shown that automated coherence estimates are vulnerable to bias, with lower
estimates for speech from people identifying as black irrespective of diagnosis. Interrogation of coherence- and
BERT-based classifiers reveals they dramatically underperform in this group also. For the parent award for this
supplement proposal (R01 LM0104056), we will develop methods to debias deep transformer networks to
mitigate for the confounding variable of provenance in multi-institutional datasets, culminating in the release of
a toolkit to Deconfound Deep Transformer Networks, the DeconDTN suite. In this proposal we will apply these
methods to deconfound coherence- and BERT-based AD detection models for the confounding variable of race
and/or ethnicity, and evaluate the effects on model performance across groups. In addition, we will evaluate the
utility of fine-tuning semantic coherence models and models used to generate automated transcripts on text and
speech from the recently-released Corpus of Regional African American Language (CORAAL). We hypothesize
that both improvements in these underlying models, and explicit deconfounding for race/ethnicity will reduce the
performance differential across groups, resulting in equitable models for language-based AD detection.

Public health relevance
Project Narrative Delayed diagnosis of Alzheimer’s Disease (AD) has devastating personal and societal consequences, and deep learning methods for detection of linguistic manifestations of AD have the potential to mediate timely diagnosis. Unfortunately, these methods underperform in racial and ethnic groups that are under-represented in their training data, with the potential to further exacerbate known inequities in the timeliness of AD diagnosis. In the proposed research we will develop methods to debias these language-based, resulting in equitable and effective models for early detection of AD.